Novel Functions for Ras family GTPases

Mutational activation of RAS occurs in approximately 30% of human tumors with some cancers such as
pancreatic cancer having RAS mutations in >90% of tumors. Although mutational activation of RAS shifts RAS
to the GTP-bound state, a number of oncogenic RAS proteins are characterized by high intrinsic nucleotide
dissociation rates. Thus, these RAS mutants, termed “fast-exchange” mutants, transiently release GTP and
transit through the nucleotide-free (apo) state. Following on our previous MERIT award that resulted in
development of high affinity tool biologics (Monobodies) that specifically and selectively bind apoRAS, we have
made a paradigm shifting discovery that these apo-specific Monobodies function as potent inhibitors of fast-
exchange, oncogenic RAS mutants. Preliminary studies suggest that these Monobodies inhibit both the
signaling and oncogenic activity of fast exchange but not slow exchange RAS mutants. Using these powerful
tool biologics, we will: 1. determine the selectivity of these apoRAS Monobodies toward various RAS mutants
and RAS family members; 2. assess the viability and selectivity of targeting apoRAS as a strategy to inhibit
RAS-mediated signaling and oncogenic transformation in vitro; 3. determine the efficacy of targeting apoRAS
in vivo as a therapeutic strategy for treating RAS-mutant pancreatic cancers; and 4. develop our apoRAS-
specific Monobodies into a preclinical anti-RAS therapeutic. Given the prevalence of RAS mutations in human
cancers and the importance of RAS in driving cancer development and progression, particularly pancreatic
cancers, it is critical to develop new approaches to therapeutically inhibit RAS in patients. Although decades of
research in the RAS field has resulted in a dearth of FDA-approved pharmacological inhibitors, recent
pioneering work has renewed hope in finally developing an anti-RAS therapeutic. Several companies have
launched clinical trials of drugs that specifically target the RAS(G12C) mutant protein based on the thiol
reactivity of the G12C mutation. Although initial results are promising, these inhibitors will only be useful in
G12C-mutant tumors which constitute roughly15% of all RAS-mutant cancers and less than 2% of pancreatic
tumors. Our findings, however, would be applicable to more than >50% of RAS mutant cancers including more
than 45% of RAS-mutant pancreatic cancers. Thus, our proposed studies in this MERIT renewal will provide
critical insights into a novel approach to inhibit RAS-mediated tumorigenesis and are thus likely to have broad
translation significance. More importantly, this work will be beneficial to Veterans as well as the general
population, both of which suffer from cancer. However, the incidence for RAS mutant cancers, such as lung
and pancreatic cancer, has been reported to be up to 5-7x higher in Veteran populations making these studies
particularly relevant to the health of our Veterans.

Public health relevance
The application will fill a critical knowledge gap in our understanding of RAS family GTPases which play a central role in many aspects of biology including growth, differentiation, and development. The medical importance of RAS is highlighted by its frequent mutational activation in ~30% of human cancers with pancreatic cancers harboring RAS mutations in >90% of tumors. We have discovered a paradigm shifting approach to therapeutically inhibit RAS signaling and oncogenic transformation through targeting nucleotide- free RAS (apoRAS). Completion of these studies will provide fundamental support for development of therapeutics targeting apoRAS. Thus, this work has tremendous translational significance and relevance for Veterans who are disproportionately impacted by RAS-mutant cancers. We anticipate that these studies will lead to the future development of small molecules RAS inhibitors that specifically target apoRAS.